Development of a Small, Durable, Hemocompatible Centrifugal Blood Pump for Children

PROJECT SUMMARY
Pediatric ventricular assist devices (VADs) are urgently needed to support children with heart failure awaiting
transplant, especially given the scarcity of donor hearts and the complications associated with congenital heart
disease. Currently, no VADs are approved for long-term use in the U.S. for children weighing approximately
10–35 kg. The immediate goal of this research is to test and refine a small and durable centrifugal blood
pump (named PSU Child VAD) that we recently developed for use in children approximately 10-35 kg (BSA
0.5-1.2 m2, 1-11 years of age, and mean cardiac output of 1.5-3.5 LPM) with the weight variation of ~±1kg for 1
year old and ~±10kg for 11 year old based on growth charts developed by the Centers for Disease Control and
Prevention (CDC). The device will be equipped with the optional near-physiologic pulsatility. A chronic in-vivo
study was conducted on a lamb for 26 days elective, demonstrating promising biocompatibility with no
evidence of end-organ failure. The goal will be achieved by three complementary, but independent aims; Aim
1) to test the prototype (Rev 0.0) PSU Child VAD through a series of 30-day in-vivo studies to validate the
design and determine if the system meets the design requirements. We hypothesize that the in-vivo studies
with PSU Child VAD will result in hemo-/biocompatible outcomes in terms of minimal blood trauma and no end-
organ failure; Aim 2) to refine the design of PSU Child VAD (Rev 1.0, 2.0) based on the outcomes from in-
silico, in-vitro, and in-vivo studies by following the FDA Design Controls approach. We hypothesize that the
FDA Design Control Approach-based design iteration will result in superior hydraulic efficiency and hemo-
/biocompatibility. This design is expected to minimize the occurrence of thrombosis, von Willebrand factor
degradation, and hemolysis while maximizing hydraulic efficiency.; Aim 3) to develop a controller capable of
providing synchronous co-pulsation to provide physiologic pulse pressures. The rationale in Aim 3 is that
continuous flow blood pumps operating at a fixed speed cause static, non-physiologic pressure waveforms,
which is known to cause physiologic dysfunction, such as gastrointestinal bleeding, reduced baroreflex
response, and destruction of von Willebrand factor (vWF). We hypothesize that the controller will be capable of
modulating the pump speed to provide physiologic arterial pulse pressure, thus balancing the physiologic
levels of vWF. The proposed work is innovative because it is specifically designed to provide long-term
(bridge-to-transplantation, BTT) cardiac support that fits the complex anatomy of children while also
accommodating their somatic growth. This is significant because it can lead to hospital discharge and avoid
the need for multiple surgeries. The long-term goal of this research is to develop a fully implantable system
with the ultimate aim of enhancing the survival and quality of life for children in BTT. If successful, the device
will directly benefit children awaiting donor hearts by significantly enhancing both their chances of survival
and overall quality of life.

Public health relevance
PROJECT NARRATIVE The proposed research aims to test and refine a compact, durable centrifugal blood pump specifically designed for children aged approximately 1-11 years, weighing between 10-35 kg, with a mean cardiac output of 1.5-3.5 LPM and a body surface area (BSA) of 0.5-1.2 m². Currently, there is no approved long-term device available for children in this age and size range. This innovative device is designed to provide long-term cardiac support that accommodates the unique anatomy of children, enabling hospital discharge and supporting their somatic growth, thereby reducing the need for multiple surgeries while they wait for donor hearts. The successful development of this device will significantly improve the quality of life and survival chances for children awaiting heart transplants.